Diversity Administrative Supplement to T32DC000014

Project summary
The overarching goal of the parent grant, T32DC000014, is to provide opportunities for postdoctoral fellows to
obtain training at a Center for research into the chemical senses—taste, smell, and chemical irritation. In
addition to specialized hands-on research training provided by faculty mentors, fellows attend instructional
courses, workshops, and Postdoctoral Journal Club meetings; they have opportunities for small-group review
of data, one-on-one assistance with clear scientific communication, and instruction on academic ethics tailored
to their stage of professional development. For each fellow, a mentoring committee composed of three faculty
helps formulate an Individual Development Plan for that fellow’s career path, tracks the fellow’s progress, helps
set practical scientific goals, suggests skill development opportunities, and provides written feedback every six
months. The long-term goal of Monell’s Postdoctoral Training Program is to train independent scientists in
chemosensory science, part of NIH’s mission to improve the nation’s health. This diversity supplement
proposal seeks funding for Vicente Ramirez, a Hispanic U.S. citizen and the first in his family to obtain a PhD.
Ramirez will contribute intellectually to the development of a research program focused on surveilling olfactory
function in the general population. This complements Ramirez's expertise in taste genetics gained from two
Diversity supplements to two parents awards, R41DC017693 and R42DC017693, led by Dr. Danielle Reed, a
Monell faculty member and multi-PI of Monell’s T32 training grant. With this additional training, Dr. Ramirez will
work in Dr. Valentina Parma's lab and be well-prepared to apply for an F32 Postdoctoral Fellowship, advancing
his career as an independent scientist in the chemical senses.

Public health relevance
Project Narrative Monell’s Postdoctoral Training Program provides the tools for young scientists to gain independence—a high- yield scientific environment, committed faculty, and coursework in a range of biomedical research areas, including the responsible conduct of research. Under this proposal, Vicente Ramirez, a Hispanic U.S. Citizen, will receive training as outlined in the parent T32 award, to contribute intellectually to the research on surveillance of smell function in the general population, which will enhance his knowledge of chemosensation by extending it to olfaction and contribute to his development as a chemosensory researcher.